North Texas ADRC - Biomarker Core

Biomarker and Imaging Core: Project Summary/Abstract
The Biomarker and Imaging Core (BIC) will provide advanced state-of-the-art imaging and molecular
biomarkers that will aid in the detection and monitoring of disease and increase our understanding of early and
potentially targetable pathogenic changes in early stages of AD/ADRD within the Alzheimer's Disease
Research Center (ADRC). We will collect standardized biomarkers and support discovery and development of
novel biomarkers centered around early protein and molecular alterations in AD/ADRD. We will provide a
robust platform for data sharing and coordination with regional and national Alzheimer's disease (AD) projects,
as well as educational training for junior investigators in AD-related neuroimaging. The BIC investigators have
complementary expertise in PET imaging, advanced neuro MRI, FDA regulatory compliance for investigational
PET radiopharmaceuticals and translational human clinical trials, development of novel tracers, as well as
extensive experience in imaging informatics and building robust image analyses pipelines for human
neuroimaging studies. Our neuroimaging activities will be built on an existing strong neuro- and molecular
imaging acquisition and analysis infrastructure led by core Co-Lead Dr. Joseph Maldjian, Director of the
Advanced Neuroscience Imaging Research (ANSIR) lab at UTSW. The BIC, in coordination with the Data
management, Informatics and Statistical Core (DMIS) core, will provide data sharing using an existing robust
platform for data sharing and coordination with regional and national databases (NACC, SCAN). The BIC
discovery activities focus on detecting early (pre-/early- symptomatic) imaging and proteomic signals in
AD/ADRD by translating the cutting-edge basic science discoveries at the Center for Alzheimer's and
Neurodegenerative Diseases (CAND) directed by BIC co-lead Dr. Marc Diamond. This will be accomplished
by evaluating these novel biomarkers on human samples and post-mortem brains collected by the Clinical and
Neuropathology cores. The BIC specific aims are to: 1) Provide advanced neuroimaging acquisition and
analysis for the ADRC; 2) Support development of novel and early protein-based biomarkers in AD/ADRD, and
3) Promote education and training of new investigators, and collaboration.